MTDNA HAPLOGROUPS IN BPD

Project Summary
Bronchopulmonary dysplasia (BPD), the most common complication in extremely preterm infants,
is characterized by impaired lung development. Decreasing oxidant stress which plays a significant role
in BPD pathogenesis remains a critical unmet need. Mitochondrial dysfunction, a known mediator of
pathological oxidant stress, disrupts alveolar epithelial function and promotes lung fibrosis. Dysfunctional
mitochondria generate more oxidants, exhibit impaired mitophagy, and trigger the release of pro-
inflammatory mitochondrial DNA-damage associated molecular patterns (mtDNA-DAMPs) and lung
injury. Furthermore, mtDNA haplogroups, which are inherited polymorphisms that vary with ethnicity,
have been implicated in various lung pathologies. Our group has observed that perinatal mesenchymal
stem cells (MSC) and human umbilical venous endothelial cells (HUVEC) mitochondrial dysfunction
predicts BPD risk and that decreased MSC mitophagy correlates with increased BPD severity. We have
also found that intranasal thyroid hormone-induced mitochondrial biogenesis is associated with
decreased hyperoxic lung injury and that mtDNA haplogroups mediate differences in hyperoxia-induced
mtDNA damage, inflammatory lung injury, and arrested lung development in newborn mice. In this
"MtDNA Haplogroups in BPD" project, we will build on these findings and test the central hypotheses that
mtDNA haplogroup variation-mediated differences in postnatal mitochondrial function, mtDNA-DAMPs
and mitophagy modulate BPD risk in infants, and that TH-mediated pulmonary mitochondrial biogenesis
can mitigate such differences to decrease neonatal hyperoxic lung injury through these specific aims:
Specific Aim 1 Hypothesis: mtDNA haplogroups modulate BPD risk through differences in
platelet bioenergetics, apoptosis, and plasma mtDNA-DAMPs in infants. Approach Determine infant
mtDNA haplogroups, platelet bioenergetics, apoptosis, plasma mtDNA-DAMPs and lung injury severity
(Jensen BPD status).
Specific Aim 2 will test the Hypothesis that mtDNA haplogroups modulate BPD risk through
differences in oxidant stress, mtDNA damage and mitophagy in infants. Approach Determine
HUVEC, MSC and platelet oxidant generation, plasma oxidant stress, mtDNA damage, and mitophagy
and lung injury severity.
Specific Aim 3 will test the Hypothesis that thyroid hormone signaling effects mitigate mtDNA
haplogroup-mediated differences in neonatal hyperoxic lung injury in mice. Approach: Expose
wildtype and MNX mice to normoxia/hyperoxia and saline/TH and measure lung damage, inflammation,
oxidant stress and single-cell genomic transcriptional/methylation differences.

Public health relevance
Project Narrative Bronchopulmonary dysplasia (BPD) is a common lung complication in premature infants, impairing their lung development and long-term respiratory health. Our research focuses on mitochondrial dysfunction and specific genetic variations called mtDNA haplogroups, which contribute to the severity of BPD. By investigating the role of mtDNA haplogroups and exploring potential therapeutic interventions, we aim to develop personalized strategies that can mitigate the risk of BPD and improve outcomes for premature infants.